PRODUCTION ASSISTANCE FOR CELLULAR THERAPIES (PACT)- CELL PROCESSING FACILITIES CELL MANUFACTURING AND PROCESS DEVELOPMENT SERVICES FOR PCT0005-02: CRYOPRESERVATION TECHNICAL STUDY

The goal of this task order is to use DMSO-mediated reactions to improve the recovery of cells that do not cryopreserve well using current cryopreservation formulations.